Deciphering the inositol phosphate code in viral pathogenesis and immunity

PROJECT SUMMARY
Inositol phosphates (IPs) are diffusible intracellular messengers (termed the “IP code”) that perform key
functions in the eukaryotic cell, yet the contributions of these molecules to immunity and host defense remains
underexplored. Through unbiased approaches, our laboratory has recently uncovered striking new roles for IP
molecules at the host-virus interface: (1) during necroptosis, a pro-inflammatory cell death mechanism critical
for antiviral immunity and (2) during infection with human rhinoviruses (RV), among the most common
infectious agents in human beings. We have found that IP kinase activity that produces the cellular IP
signature (i.e., IP3, IP4, IP5, IP6) is critical for both necroptosis and RV infection via apparently distinct
mechanisms. We showed that IP molecules can directly control the necroptotic executioner, mixed-lineage
kinase like (MLKL), to unleash necrotic cell death. In contrast, we found that RV infection depends on IPs at a
stage preceding cell death and independent of MLKL, indicating as yet unidentified host or viral targets for IPs.
However, it is currently unknown how the different IPs act to control these processes on a molecular level, how
IP kinases precisely collaborate to determine the cellular IP code, and how this code is regulated during
infection or cytokine stimulation to mediate immunity. Our central hypothesis is that inositol phosphates and
their kinases play important regulatory roles in innate immune responses and during viral infection through
interactions with host or viral targets. Here, we will determine the precise mechanisms for engagement of the
inositol phosphate code by these fundamental immune processes by employing a robust genetic and
biochemical toolkit and combining our expertise in molecular genetics and virology with a collaborative team of
leading experts in inositol phosphate biology and biochemistry. Specifically, we will (1) map the genetic and
physical interactions of IP species with the necroptotic executioner MLKL in cellular and biochemical assays,
and (2) define the molecular mechanism(s) governing regulation of RV infection by the IP code. Together,
these studies will provide fundamental insight into regulation of immune defenses and viral pathogenesis. We
expect this work to form a foundation for understanding the roles of the IP code in immunity and infection
biology and to provide a basis for development of novel methods to enhance anti-microbial and anti-
inflammatory therapeutics.

Public health relevance
PROJECT NARRATIVE Necroptosis is a proinflammatory form of cell death that is important in numerous disease states including viral and bacterial infections, neurodegenerative disorders, ischemic injury, and cancer. Human rhinoviruses (RV) are a major global health and economic burden. A thorough understanding of how the cellular IP signaling pathway potently regulates RV infection and necroptosis will be a foundation for rational antiviral and immunomodulatory drug design.